Core A: Administrative Core

PROJECT SUMMARY – CORE A
The goals of the Administrative Core, (Core A), are to provide coordination and integration of all Projects and
Cores and within this Program Project Grant “Integrated mechanisms of primary and chronic graft dysfunction
following lung transplantation”. The goal of the Administrative Core is to disseminate resources, primary data,
and scientific results between the PPG investigators and the larger scientific community. The Administrative
Core will accomplish these objectives as outlined in these Specific Aims:
Aim 1. To support communication between Project Investigators, Core Leaders, collaborating
investigators and NHLBI Program.
Aim 2. To provide a structure for the distribution of common resources as well as regulatory and
budgetary oversight for Project Investigators and Core Leaders.
Aim 3. To disseminate the discoveries made by PPG investigators through support of publications and
presentations, and to implement sharing of materials, protocols and raw data to other institutions and
investigators, including NHLBI-directed public databases/repositories.
Aim 4. To foster an environment of collaborative interdisciplinary research and mentoring of students,
post-doctoral fellows, and investigators.
Core A will be led by Dr. Ankit Bharat, an accomplished transplant surgeon-scientist with expertise in both innate
and adaptive immunity. Dr. Bharat serves as the Chief of Thoracic Surgery at Northwestern, Director of the
Canning Thoracic Institute (CTI) and Director of Innovation in the Simpson Querrey Lung Institute for
Translational Sciences (SQLIFTS). As the goals of SQLIFTS, the CTI and this PPG are aligned, the resources
existing and being developed at Northwestern to advance clinically actionable fundamental discoveries in lung
transplant immunology will provide an excellent environment and support structure for the work proposed in this
application.